The role of renal fibroblast alphav integrin in tubulointerstitial fibrosis

DESCRIPTION (provided by applicant): Chronic kidney disease (CKD) affects over 26 million Americans. Agents that can directly halt the progression of CKD at the cellular and molecular level are much needed but lacking. The common pathway of CKD is renal fibrosis. Fibroblasts are key effectors of fibrosis by mediating aberrant remodeling of extracellular matrix (ECM). The epithelium-restricted αv integrin, αvβ6 directly activates latent TGFβ which in turn regulates fibroblast activity. Until recently much less was known about renal fibroblast αv integrins. Our laboratory deleted all αv integrins from activated myofibroblasts and found that these mice were dramatically protected from renal fibrosis following unilateral ureteral obstruction (UUO), an established model of tubulointerstitial fibrosis. Integrins are a family of transmemebrane cell-matrix receptors consisting of a α and a β subunit. In contrast to αvβ6 whose expression is restricted to the epithelium, the other four αv integrins, αvβ1, αvβ3, αvβ5 and αvβ8 can be expressed in fibroblasts. All can bind and/or activate TGFβ, a central fibrogenic factor, in vitro. Moreover, αv integrins have been shown to work synergistically with growth factor receptors to initiate common downstream signaling pathways to regulate cell growth. The goal of this research is to determine which αv integrins are expressed on pathologic renal myofibroblasts and how one or more of these integrins modulates the behavior of myofibroblasts to cause renal fibrosis. We will examine 3 interrelated candidate mechanisms - direct activation of latent TGFβ, enhancement of fibroblast proliferation and/or enhancement of differentiation into pathologic myofibroblasts. We will determine whether any of these effects of integrin signaling are regulated by its association with growth factor receptors. We also seek to identify which specific αv integrin(s) contributes to the renal protective effects we saw in conditional αv null mice. Global genetic deletion of β3 and β5 or fibroblast specific β8 deletion did not protect mice from liver fibrosis, suggesting that in that model either multiple fibroblast αv integrins contribute or fibrosis depends on αvβ1. Until now it was not possible to study the in vivo role of αvβ1 since mice lacking β1 on myofibroblasts do not survive. To address this problem we have recently developed a highly potent and specific small molecule inhibitor of αvβ1. We will take advantage of this novel compound as well as lines of mice that have already been generated in the laboratory to determine the identity of the critical αv integrins that contribute to renal fibrosisin vivo. In summary, through this study, we will identify specific fibroblast αv integrins and their signaling pathways essential for renal fibroblast activation. The experience and track record I gain from these studies, together with planned coursework and participation in external training programs should provide me with the skill set required to launch a successful academic career as a nephrology physician-scientist.

Public health relevance
Chronic kidney disease (CKD) and eventual organ failure is a major health care concern in the U.S. underscoring the urgent need for therapies to directly halt disease progression before organ failure. This research proposal stems from our recent exciting findings that blocking proteins called αv integrins in mice protected them from kidney failure. Here, we propose to characterize the underlying mechanisms and test compounds we generated that specifically block these integrins to see if they protect mice from kidney failure. f so, these compounds may give rise to novel treatments for CKD.